Penn Artificial Intelligence and Technology Collaboratory for Healthy Aging

The overarching goal of our proposed Penn Artificial Intelligence and Technology (PennAITech)
Collaboratory is to identify, develop, evaluate, commercialize, and disseminate innovative technology for
monitoring aging adults and those with Alzheimer’s Disease (AD) and Alzheimer’s Disease Related Dementias
(ADRD) in their home environment and the artificial intelligence (AI) methods and software for analyzing data
generated by those technologies. The collaboratory is motivated by the need for a comprehensive pipeline from
technology-based monitoring of aging adults in the home, collection and processing monitoring data, integration
of those data with clinical data from electronic health records, analysis with cutting-edge AI methods and
software, and deployment of validated AI models at point of care for decision support. We have assembled a
team of experts with experience building and implementing each component of this pipeline and will promote
this vision and existing tools and software (AIM 1). A central focus of the PennAITech Collaboratory is to advance
this vision through the solicitation, review, and funding of pilot grants focused on technology and AI development
to advance the science of care management and aging in place for vulnerable older adults or those with
AD/ADRD receiving skilled home and community-based services (AIM 2). Funded pilot projects will be supported
in AIM 3 through cores focused on administration (Core A), stakeholder engagement (Core B), technology
identification and training (Core C), clinical translation and validation (Core D), networking (Core E), and ethical
and policy issues (Core H). Finally, the collaboratory will work closely with the planned coordinating center to
facilitate the success and translation of all collaboratory projects (AIM 4). We are committed to improving the
health of aging adults and those with AD/ADRD through these specific aims.

Public health relevance
Successful aging in the home can greatly improve quality of life, improve health outcomes, and reduce burden on the healthcare system. The goal of this project is to establish a national collaboratory for the development, evaluation, and implementation of artificial intelligence software and new technologies to facilitate health aging in the home. The collaboratory will include a diversity of experts including clinicians, computer scientists, engineers, patients, and caregivers to facilitate this goal.